Neuropeptide Y: Role in Ethanol Intake and Sensitivity

Project Summary/Abstract Alcohol (ethanol) dependence and relapse in abstinent alcoholics are major health problems throughout the world and neurochemical pathways that modulate these disorders are currently under investigation. However, the neurobiology underlying binge drinking, a dangerous pattern of behavior that proceeds and contributes to dependence, has received far less attention. Thus, it is of paramount importance to identify the neurocircuitry in the brain that modulates binge drinking as such knowledge will provide insight into the initial stages of alcohol use disorders (AUDs). This application represents the request for a diversity supplement for the parent grant that aims to study the role of neuropeptide Y (NPY) in the modulation of voluntary binge-like ethanol drinking in mice. The trainee is an undergraduate student going into his senior year at the University of North Carolina at Chapel Hill. The research and career development training plan that is outline in this supplement will be critical to keep the trainee on an accelerated trajectory so that he will be well prepared and highly competitive when he transitions to the next level of training as a post-baccalaureate researcher and subsequently as a graduate student with a focus on the neurobiology of alcoholism. Tasks will include working with the trainee directly on literature searches, critical analysis and reviews of papers in lab meetings and journal clubs in which the trainee learns to more effectively organize his thoughts on research and pass this information along to colleagues, and direct supervision of the trainee in the lab as he learns new neuroscience techniques. There are four main training activities associated with this plan: 1) training in ethics, 2) training in written and oral communication, 3) training in networking to identify a postbaccalaureate mentor, and 4) laboratory research training. With respect to research training, the trainee will be directly involved with the Specific Aims proposed in the parent grant, as well as training outlined in this supplement in which he will assess the role of corticotropin releasing factor (CRF) neurons that express NPY Y1 receptor (Y1R) in the modulation of binge-like ethanol intake in mice. He will study these CRF/Y1R+ neurons in a circuit originating in the central amygdala and innervating the lateral habenula. During these experiments the trainee will learn new cutting-edged neuroscience technologies, including confocal microscopy, RNAscope, immunohistochemistry, and chemogenetics. The training outlined in this supplement will be essential in helping the trainee achieve his short-term goal of becoming a highly competitive candidate for securing a postbaccalaureate position in a strong research laboratory, and his long-term goal of securing a graduate student position at a top university that will allow him to continue pursuing his research interests in the neurobiology of alcoholism.

Public health relevance
Project Narrative Research has established that compounds aimed at neuropeptide Y (NPY) receptors are protective against dependence-induced alcohol drinking, and our recent findings show that compounds targeting NPY receptors are also protective against excessive binge-like drinking in mice when targeted to regions of the extended amygdala. Expected results in the current application will significantly expand our recent observations by showing the NPY circuits in the medial prefrontal cortex modulate binge-like ethanol drinking by providing top- down modulation of the extended amygdala.